Molecular mechanisms of DNA damage signaling and repair

Project Summary/Abstract
Project Summary/Abstract is included in the Scientific Justification of the Research Strategy section.

Public health relevance
Project Narrative - original application Human cells are challenged constantly by genotoxic stress of both environmental and intracellular origins. The ability to maintain the structure and function of the DNA replication machinery in the face of genotoxic stress is key to the prevention of cancer and other diseases. This proposal seeks to decipher a novel calcium- dependent signaling pathway that is essential for the protection of the replication machinery, with the ultimate goal of developing more effective cancer treatment strategies.